Role of GPIba Receptor Shedding in Platelet Dysfunction Following Trauma

DESCRIPTION (provided by applicant): Traumatic injury is the third leading cause of death in the US and about 40% of these deaths are due to hemorrhage. One quarter of all trauma patients experience prolonged hemorrhage due to impaired blood clotting (coagulopathy). These patients suffer from excessive bleeding disproportionate to their injuries, a phenomenon that is poorly understood. Achieving hemostasis following injury is crucial to controlling blood loss and platelets are critical regulators of this process. Platelet adhesion to damaged endothelium is mediated by von Willebrand factor (vWF) binding to the GPIbα receptor on activated platelets. Preliminary data show that platelet adhesion to vWF was significantly reduced following injury. In addition, these patients displayed reduced platelet GPIbα receptor expression and increased shedding of GPIbα into the plasma, suggesting a possible mechanism behind defective platelet-vWF adhesion. The long-term goal is to understand the contribution of platelet receptor shedding to platelet dysfunction and bleeding in trauma patients. Shedding of GPIbα is proteolytically regulated by tumor necrosis factor-α converting enzyme (TACE), which modulates platelet-vWF adhesion through cleavage of GPIbα. Preliminary clinical results show a substantial increase in TACE expression on platelets following injury. Therefore, the objective of this application is to determine the contribution of TACE-mediated GPIbα receptor shedding to the defective platelet-vWF adhesion observed following traumatic injury. The central hypotheses are: 1) Excessive hemorrhage in trauma patients results from defective platelet-vWF adhesion due to inappropriate shedding of GPIbα; 2) This shedding is mediated by elevated TACE, and can be corrected through TACE inhibition. The rationale for this research is that understanding the effects of injury on platelet-vWF binding will allow identification of the mechanisms behind life-threatening hemorrhage and develop pharmacologic interventions to alleviate bleeding. These hypotheses will be tested by pursuing two specific aims: 1) Identify the mechanisms behind defective platelet-vWF adhesion following traumatic injury; and 2) Characterize the effect of TACE absence and inhibition on platelet GPIbα receptor expression and hemostasis in a mouse model of trauma and hemorrhage. Under the first aim, serial blood samples will be collected from severely injured patients to measure effects of injury and resuscitation fluids on expression of platelet GPIbα and TACE by flow cytometry and shedding of GPIbα by ELISA. Under the second aim, TACE absence and inhibition will be tested in a mouse model using both platelet-specific TACE knock-out mice and TACE inhibitors in wild-type mice to determine the effects of TACE absence and inhibition on preserving GPIbα receptor expression. This approach is innovative because it utilizes both human and animal subjects and a unique patient population rarely studied in the lab setting. The proposed research is significant because the results will identify strategies to facilitate more effective platelet- vWF binding, which could subsequently improve primary hemostasis in hemorrhaging trauma patients.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed research is relevant to public health because determining the mechanisms behind defective platelet-vWF adhesion following traumatic injury and the role of platelet receptor shedding in this process is expected to identify pharmacologic targets to improve outcomes in trauma patients experiencing substantial hemorrhage. Therefore, the proposed research is relevant to the NIH mission of reducing morbidity and mortality in the United States.